A Modern Data Science Approach to Enhance Caregiver Support for Behavior Management in Children with ASD

SUMMARY
Autism Spectrum Disorder (ASD) involves challenges in social communication and intensive, restricted, or
repetitive behaviors and/or interests. Sensory atypicalities are prevalent in approximately 74% of individuals
with ASD, can range from pleasurable experiences to distressing outbursts caused by hypersensitivity affecting
self-control and decision-making. Severe outbursts may lead to self-harm. However, proactive strategies to
prevent these outbursts are under-researched and underutilized compared to reactive approaches. This study
aims to develop algorithms predicting outbursts using wearable biosensor data and advanced machine
learning (ML) models. It is aimed at enhancing caregiver support for individuals with ASD using modern ML
frameworks. We accomplish this goal across three aims. Aim one’s objective is the collection of a novel
dataset of the peripheral physiological and movement precursors of outbursts. We accomplish this aim by
observing such events naturally in children with ASD who are prone to such behaviors using wearable
wristband-based biosensors along with recording devices to capture potential triggers. Aim two characterizes
the peripheral physiological indicators as individuals progress into and through an outburst, exploring internal
stages of dysregulation that comprise these behaviors. In this aim, we use statistical analysis to identify
differences in the stress-reactivity profile, which inform later ML models. Aim three seeks to develop predictive
ML algorithms capable of predicting outbursts that occur in individuals with ASD. Altogether, our study will lay
technology capable of detecting the precursors of
outbursts in real-life situations using state-of-the-art wearable devices and artificial intelligence (AI) algorithms.
This technology could deliver immediate alerts for parents or caregivers, providing individualized
recommendations to prevent or mitigate the severity of an imminent outburst, developed using evidence-based
behavioral interventions. Moreover, as proactive strategies for preventing outbursts are under-researched
compared to reactive strategies, and the fact that it is little known about the underlying mechanisms associated
with an outburst, our results
the foundations of our long-term aim: the development of
will also contribute to a better understanding of the nature of outbursts and a more
detailed and operationalized description of their physiological correlates.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it aims to shed light on the physiology of outburst behavior in children with Autism Spectrum Disorder (ASD) and to identify physiological stress response indicators that may predict an impending outburst in real-life situations. We will build a framework for the development of an early notification system for predicting outburst behavior, which promises to enhance the quality of life for individuals with ASD and their families by reducing the impact of sudden, negative emotional outbursts and providing timely support. This project is relevant to the NIH’s mission because it seeks to understand fundamental biological mechanisms associated with potentially harmful, sudden, and often uncontrollable behavioral outbursts in children with ASD. .